NUCLEAR TRANSFER IN RHESUS MONKEYS

OBJECTIVE: To test various nuclear transfer strategies to generate genetically identical rhesus monkeys. RESULTS The role of Dr. Thomson's laboratory in this project is to derive new rhesus ES cell lines and provide them to the Oregon Regional Primate Center for nuclear transfer experiments. During 1997, we began weekly shipments of early passage rhesus ES cell lines, and derived a new rhesus ES cell line. FUTURE DIRECTIONS We anticipate that we will derive 6 new rhesus ES cell lines per year and provide them to the Oregon Regional Primate Research Center.